PP2A/B55alpha substrate specificity and function in cell cycle progression

The goal of this proposal is to fully delineate the molecular mechanisms by which the prominent serine/threonine
Protein Phosphatase 2 (PP2A) holoenzyme, specifically PP2A/B55α, recognizes its substrates through a new
helical motif and to use this information to identify direct PP2A/B55α substrates with functions in mitogenic
signaling and early cell cycle progression. Protein phosphorylation is an essential regulatory mechanism in cell
signaling and the regulation of the cell cycle and it is altered in cancer, Alzheimer, and other diseases. A large
fraction of dephosphorylation is mediated by distinct PP2A trimeric holoenzymes. These consist of a scaffold
protein that connects the catalytic subunit to the variable regulatory subunit, which mediates substrate specificity.
The most abundant holoenzyme is PP2A/B55α. Its activity has been implicated in mitogenic signaling and early
cell cycle progression, but details remain unclear. Initially, it was believed that PP2A/B55α recruited substrates
through charge-charge interactions between the surface of B55α and substrates. However, our groundbreaking
discoveries challenged this notion. We identified a conserved amino acid motif in various proteins, including the
p107 substrate and the FAM122A inhibitor, that folds as an a-helix. This helical motif is essential for p107
dephosphorylation and for FAM122A binding via similar interactions with residues in a groove on the top of B55α.
This mechanism is distinct from that used by other Ser/Thr phosphatases that bind short linear motifs in
intrinsically disordered protein regions. Gap: Despite this advance, we remain unable to identify other
PP2A/B55α substrates using this short helical sequence. This is due to the lack of a comprehensive assessment
of amino acid variability within the helical motif sequence and incomplete detail of the motif’s structural plasticity.
As a result, it remains extremely difficult to identify new substrates, to distinguish correctly vs incorrectly assigned
substrates, and to demonstrate the veracity of correctly assigned substrates. We hypothesize that a helical
region with a defined length and a variable conserved amino acid sequence in PP2A/B55α substrates mediates
binding to the top groove of B55α via specific electrostatic and hydrophobic interactions. This is a primary
mechanism for substrate recognition that modulates signaling through the cell cycle. These will be tested with
two aims: (1) To define PP2A/B55α substrate specificity via a short helical motif with defined sequences. (2) To
dissect the PP2A/B55α substrate interplay in mitogenic signaling linked to the cell cycle Restriction Point (RP).
DEIA Aims: Diversity among Temple University undergraduates is excellent, but the transition of
underrepresented minority (URM) students to biomedical science research careers or graduate schools is still
severely limited. Our goal is to implement a program we have been piloting that is geared toward eliminating
barriers to joining the scientific research workforce faced by URM undergraduates at Temple and nationwide.
The program will recruit 15 students who will work in mentors’ labs on a specific project and receive programmatic
training to prepare them for admission and success in Biomedical Research PhD programs. Aim 1 is to develop
research skills and knowledge and Aim 2 is to develop career skills by providing instruction in fellowship writing,
graduate school application, oral and writing scientific communication, and scientific networking.
Successful completion of the scientific Aims will facilitate identification of PP2A/B55α substrates and their
validation in multiple pathways and cellular processes often deregulated in disease providing novel targets for
therapeutic intervention. The DEIA training program will guide URM students to professional research careers.

Public health relevance
In response to PAR 23-122, this application encompasses both Scientific and DEIA Aims. Scientifically, it revolves around elucidating the substrate specificity of a newly discovered helical motif in substrates of the PP2A/B55α phosphatase. Simultaneously, it aims to implement a comprehensive Fels Biomedical Research URM Undergraduate Training Program (Fels-BR-U2) tailored for Temple University (TU) undergraduates from historically underrepresented (HUR) groups.